Reproductive Scientist Development Program (RSDP) - NCI Supplement

Project Summary/Abstract
The Reproductive Scientist Development Program (RSDP) is a multi-disciplinary, multi-institutional research
career development program for obstetrician-gynecologists in cell and molecular biology and related
fundamental sciences. The objective of this program is to educate obstetrician-gynecologists in contemporary
basic science research related to reproductive medicine and biology in order to prepare them for research
careers in academic medicine. The overall goal is to help ensure that academic obstetrics and gynecology
fulfills its mission to increase research and discovery in the reproductive sciences. Outstanding MD/PhD,
PhD, and MD scientists with broad research experience serve as faculty mentors.
A unique feature of this program is that outstanding individuals, upon completing a residency in obstetrics
and gynecology, and in most cases two or three years of clinical subspecialty fellowship, spend two years
(Phase I) in fundamental science research laboratories under the supervision and mentorship of experienced,
highly regarded accomplished scientists. During Phase I, Scholars are dedicated to full-time research with no
clinical obligations. Following this experience, Scholars spend an additional two-year period establishing their
research program in a Department of Obstetrics and Gynecology (Phase II). Here, the Scholar serves as a
junior faculty member with at least 75% time devoted to developing an independent research career. For the
past five (5) years, salary support for scholars has been provided mainly by NICHD, while support for
research related expenses has been provided from the various non-federal agencies who contribute to the
RSDP program.
The RSDP has a rich history of educating young physician scientists in Obstetrics and Gynecology and
replenishing the pipeline of reproductive scientists and is committed to continuing its objective of producing
the next leaders of our academic obstetrics and gynecology departments. With funding thru this supplement,
the program can address the relative dearth of applicants and scholars in the subspecialty of gynecologic
oncology and help to fill an urgent need for well-trained physician scientists in this subspecialty.

Public health relevance
Project Narrative The Reproductive Scientist Development Program (RSDP) plan for career development serves as a model for postgraduate medical education and assures that some of the most promising young physician-investigators in the country will remain in academic investigative obstetrics and gynecology. Despite an urgent need for research in gynecologic oncology, less than 1 in 5 of the 114 RSDP trainees to date have represented that subspecialty. This supplement grant seeks a new funding source specifically directed to attracting, training and retaining gynecologic oncologists as career physician scientists.